CLINICAL OUTCOMES IN MEDIUM CHAIN ACYL COA DEHYDROGENASE DEFICIENCY

The purpose of this study is to determine the psychodevelopmental outcome of patients with the Medium Chain Acyl-CoA Dehydrogenase Deficiency. This study also seeks to examine the relationship of hypoglycemia and seizures to developmental abnormalities in this population.